Mechanisms underlying mustard gas-induced conjunctival injury and use of lipid mediators as medical countermeasures

PROJECT SUMMARY
Mustard gas (MG, most commonly sulfur and nitrogen mustard) is a highly toxic vesicant that causes ocular
injuries in over 90% of exposed victims with symptoms lasting from minutes to years. These symptoms include
conjunctivitis in addition to eye pain, photophobia and corneal epitheliopathy. Moderate to severe exposure to
MG results in chronic or latent (delayed-onset) forms of symptoms that include changes in the conjunctiva such
as vascular abnormalities and histopathology including reduced goblet cell (GC) density and lymphocytic
infiltration. However, mechanisms of toxicity and therapeutic targets in the conjunctiva remain largely unknown.
We reported that in addition to protective soluble mucin, MUC5AC,GCs are a source of pro-inflammatory IL-1β
as well as immunomodulatory TGFβ and therefore play a role in shaping both local innate and adaptive
immune responses. The contribution of GC secretory products to ocular mucosal homeostasis is further
underscored by the observed chronic inflammation and related epitheliopathy associated with loss of GCs or
GC-derived regulatory factors. Specialized pro-resolving mediators (SPM) like D-series resolvins RvD1 are
endogenous lipid derivatives produced during inflammation are known to accelerate its resolution and
restoration of tissue architecture. We reported that RvD1 can inhibit secretion of GC-derived IL-1β. In this
proposal we will identify mechanisms underlying MG toxicity in the conjunctiva and its contribution to chronic
pathology. We will determine if SPMs restore homeostasis in the conjunctiva to prevent chronic damage
caused by MG and serve as effective medical counter measure (MCM) for ocular toxicity of MG. We
hypothesize that SPMs promote resolution of MG-induced ocular damage by modulating secretory and
homeostatic function of conjunctival GCs. To address this hypothesis, the following three specific aims are
proposed. Aim 1: Identify nitrogen mustard (NM)-induced alteration in conjunctival epithelial GC function and
the potential of SPMs to resolve NM toxicity and restore GC function in vitro; Aim 2: Determine if NM exposure
disrupts immune homeostatic function of GCs in vitro and if SPMs can restore it; and Aim3: Determine
therapeutic efficacy of RvD1 as a MCM, in vivo, using a mouse model of NM toxicity. Conjunctival and corneal
damage as well as ocular surface innervation will be evaluated. Our anticipated results from these studies can
reveal the potential of conjunctival GCs as a MG injury site and therefore a therapeutic target and provide
critical insights into developing novel strategies to promote mucosal and immune homeostasis in clinical
management of MG-induced ocular toxicity.

Public health relevance
PROJECT NARRATIVE Mustard gas injury to the eye causes damage that includes inflammatory response and conjunctivitis. This project will determine the contribution of disrupted conjunctival goblet cell secretory and homeostatic functions to chronic effects that follow vesicant injury. Using in vitro and in vivo approaches this study will also determine if lipid specialized pro-resolving mediators such as D-series resolvins offer a novel medical counter measure to promote ocular mucosal and immune homeostasis by targeting conjunctival goblet cells.